Diversity Supplement: Uncovering diverse genotype-phenotype relationships in prostate cancer

Project Summary
A significant challenge in the field of functional cancer genomics is to establish experimental systems with
biologic relevance, economy, and scale to derive insights into the interactions of diverse genetic events in
cancer initiation and progression. We developed a next-generation functional cancer genomics assay that
combines efficient delivery of random, compound genetic perturbations from barcoded lentiviral libraries
encoding gain-of-function and/or loss-of-function events; biological selection for a cancer phenotype; and
single-cell DNA amplicon sequencing analysis to enumerate lentiviral barcodes for the massively parallel
association of genotype with phenotype (histology). Here we will substantially improve upon this prototype
assay by modifying the lentiviral constructs such that they incorporate and transcribe DNA barcodes that can
be captured by single-cell RNA sequencing, thereby enabling simultaneous single-cell determination of
lentiviral barcodes (genotype) and transcriptomes (phenotype). To accomplish this, we will engineer DNA
barcodes and a simian virus 40 polyadenylation signal sequence into the 3’ untranslated region of a green
fluorescent protein (GFP) expressed from an internal cytomegalovirus (CMV) promoter. We will also enhance
overall GFP transcription and mitigate CMV promoter silencing by placing a ubiquitous chromatin opening
element (UCOE) upstream of the CMV promoter. Further, we will determine technical parameters related to
single-cell RNA sequencing to determine the relative read depths necessary to accurately capture compound
barcodes and discriminate cell populations based on transcriptional profiles from a defined cell mixture. Once
optimized, this technology will be incorporated into an established mouse prostate epithelial transformation
assay to demonstrate proof-of-principle of this approach and define how oncogenic events may cooperate to
impart distinct prostate cancer cell states. This diversity supplement will support Gerardo Javier, a graduate
student at the University of Washington who is conducting research under the primary mentorship of John K.
Lee, MD, PhD at Fred Hutch. He will also receive co-mentorship from McGarry Houghton, MD who is a senior
faculty member at Fred Hutch. A training plan has been crafted to ensure Gerardo’s enrichment related to
scientific productivity, education, communication skills, professional development, networking, and promotion
of underrepresented minorities in biomedical sciences. This support will be beneficial to his training as a
graduate student focused on cancer biology and his ultimate transition to a post-doctoral fellowship as he
continues his career trajectory of becoming an impactful independent cancer researcher.

Public health relevance
Project Narrative The proposed research will establish a revolutionary and widely applicable experimental strategy with the scale and throughput to understand how diverse gene mutations found in cancer cooperate to influence aggressive behaviors of cancer cells. The approach will rapidly advance our understanding of the genetic basis of prostate cancer and accelerate the generation of prostate cancer models that mirror the genetic complexity of the disease.